Multi-modal spatial genomics in the mouse and human brains

SUMMARY
The major goal of this project is to build upon our existing expertise and platform to develop
spatial multi-omics tools in human brains. At Spatial Genomics, we are commercializing the
sequential fluorescence in situ hybridization (seqFISH) technology (Eng et al, 2019) that allows
thousands of genes to be imaged directly in brain samples. We have developed extensive
experience working with mouse and human brains with our seqFISH technology. Spatial
genomics methods have the potential to identify novel cell types, reveal spatial organization of
groups of cells and subcellular patterns, and elucidate signaling interactions between
neighboring cells in the brain. Identifying the spatial organization of the human brain at cellular
resolution from single cell gene expression profiles is essential to understanding neuronal
circuits and interactions between neurons and glia.

Public health relevance
NARRATIVE Mapping the spatial organization of the human brain at cellular resolution from single cell gene expression profiles is essential to understanding the function of neurocircuits in the brain. Spatial Genomics has developed a technology to map cell populations and molecular states of single cells in their native environment. This technology can identify cell types and the spatial interactions between neurons and glia in the brain to generate a spatial map with molecular information.